PET imaging of Chemotherapy-Induced Cardiotoxicity

Title: PET Imaging of Chemotherapy-Induced Cardiotoxicity
Abstract.
Cardiovascular disease is now the second leading cause of long‐term morbidity and mortality among cancer
survivors. Both conventional chemotherapy and targeted therapies are associated with an increased risk of
myocardial damage, resulting in left ventricular dysfunction and heart failure. Overall, cardiotoxicity from
chemotherapeutic agents have been observed with drugs encompassing wide range of structural domains,
including anthracyclines (Doxorubicin), alkylating agents (Cisplatin), taxanes (Paclitaxel), and monoclonal
antibodies (Herceptin etc). Therefore, noninvasive detection strategies capable of providing a very early and
specific readout prior to development of decreased cardiac function could significantly impact patient care,
allowing for early treatments of cardioprotective therapies and modification of chemotherapeutic regimens. To
accomplish this objective, our team has developed 68Ga-Galmydar, a novel PET tracer which gives a highly
sensitive and specific functional readout of mitochondria status within the myocardium. Deploying the fluorescent
traits of this molecular imaging probe, we have performed live-cell fluorescence imaging which has shown a
gradual decrease in uptake and retention of Galmydar within mitochondria of H9c2 cells following DOX-treatment.
Data show uptake profiles that are both dose- and time-dependent. 68Ga-Galmydar micro-PET/CT imaging
demonstrates a 1.91-fold lower uptake and retention in hearts of DOX-treated rats compared to their vehicle
treated control counterparts. Biodistribution studies performed post-imaging also confirm these imaging derived-
SUV data. These data strongly indicate that 68Ga-Galmydar PET imaging has the potential to serve as a
noninvasive strategy for the detection of DOX-induced cardiotoxicity at earliest stages. Armed with this
provocative preliminary data, the specific aims of this RO1 proposal are: 1) A. Assess the potential of 68Ga-
Galmydar to monitor chemotherapy (DOX, Paclitaxel, Herceptin)-induced cardiotoxicity with or without cardio-
protectants and perform comparative analysis with 2 reference standards (13N-Ammonia; perfusion and cell
viability marker) and fasting 18F-FDG (inflammation marker) in rabbit models in vivo. B. Validate the potential of
68Ga-Galmydar PET imaging to provide early detection of cardiotoxicity prior to other imaging-demonstrable
functional and structural myocardial abnormalities. Specifically, PET findings will be compared to MRI-determined
myocardial strain, and native myocardial T1 values, T2 values, extracellular volume (ECV), and late gadolinium
enhanced (LGE) imaging, under identical conditions. Rabbit models will be imaged with PET/MRI. 2) Evaluate
68Ga-Galmydar potential for noninvasive detection of chemotherapy-induced cardiotoxicity in breast cancer (n=10)
and lymphoma patients (n=20, 15 males and 5 females) and perform comparative analysis with 18F-FDG to evaluate
concurrent myocardial inflammation (as positive contrast to expected 68Ga-Galmydar signal decrease) in same
participants. Successful completion of the proposed aims will deliver a versatile molecular PET imaging tracer for
monitoring earliest stages of myocyte impairment in patients undergoing chemotherapy, thus steering the field
towards imaging-guided stratification of treatment plans within medical oncology and benefiting the management
of cancer patients.

Public health relevance
Conventional chemotherapy and targeted therapies are associated with an increased risk of myocardial damage, resulting in left ventricular dysfunction (LVD) and heart failure (HF). Currently, cardiac magnetic resonance imaging is used for measuring myocardial volume, mass, strain, and assessment of tissue function, however, its benefits are offset by high costs and lack of compatibility for many patients with implanted ferromagnetic devices. Current guidelines to detect chemotherapy-induced cardiotoxicity are also based on evaluating global systolic function, wherein the left ventricle ejection fraction (LVEF) is assessed by nuclear gated blood pool studies or cardiac ultrasound. However, the assessment of LVEF is also variable, and offers a limited utility to detect early cardiotoxicity, as many patients demonstrate histological evidence of cardiotoxicity before significant decrease in systolic function. Therefore, there is an urgent unmet need for development of noninvasive diagnostic test to enable earliest detection of chemotherapy- induced cardiotoxicity. This project is focused upon preclinical translational imaging 68Ga- Galmydar, a PET tracer in higher vertebrates to establish analysis protocols for assessment of its sensitivity for detecting chemotherapy-induced cardiotoxicity (at earliest stages than currently available state of the art techniques) via a pilot imaging (68Ga-Galmydar; IND# 157468; PI: Dr. Woodard) study in breast cancer and lymphoma patients. 68Ga-Galmydar shows highly promising data in doxorubicin-induced cardiotoxicity model and is a highly worthy candidate for further validations in higher vertebrates, and translation into clinic. Overall, successful realization of the proposed aims would facilitate translation of the PET tracer into clinic, and enabling stratification of chemotherapeutic choices, and modification of plans for cohorts with LVD thus transforming clinical healthcare in medical oncology towards image-guided personalized medicine to manage complications from cardiotoxicity.